CORE--IMAGE QUANTITATION AND VISUALIZATION

Specialized Resource 4-Image Quantitation and Visualization Resource (Dr. Plevritis/Napel Co-PI's): This resource is designed to help ICMIC at Stanford investigators understand, quantitate, mathematically model, statistically analyze, and visualize their multimodality imaging data. We feel it is critical that molecular imaging move forward with not only the ability to obtain images but to rigorously quantitate the obtained data. This resource will help to make sure that investigators are confident in understanding and reporting the data obtained. This resource will work closely with Specialized Resource #9003 and will be utilized by all Research and Developmental Projects.